Structure-based computational engineering of saCas9 PAM requirement

ABSTRACT
SaCas9 is a major gene editing nuclease that is preferred for in vivo applications thanks to its
relatively smaller size compared to that of spCas9. One limiting factor for the use of saCas9 is
its strict PAM requirement of NNGRRT. In addition, there are limited efforts to reduce saCas9’s
off-target editing rates. In Aim 1, we propose a computational approach to relax saCas9’s PAM
requirement. We hypothesize that the interactions between key PAM recognition (KPR)
residues of saCas9 and the side chains of PAM nucleotides determine the PAM requirement,
and that mutating KPR residues by destroying their interactions with the DNA side chain while
introducing favorable interactions with the DNA main chain will relax the PAM requirement. We
have demonstrated the feasibility to relax the PAM requirement to NNNRRT in preliminary work.
Here we will develop and optimize a computational method UniDesign to engineer saCas9s with
further relaxed NNNRRN PAM (rr-saCas9s). In Aim 2, we propose to improve rr-saCas9’s
safety. Recently we reported the development of mispCas9, in which a small size (36 amino
acids) HDR (homology-directed repair)-promoting peptide Brex27 was fused to spCas9.
Compared to spCas9, mispCas9 leads to increased knock-in rates as well as reduced off-target
insertion and deletion (indel) events. Importantly, Brex27 can be used as a “plug and play”
module to improve other gene-editing nucleases as long as their mechanism of action depends
on the generation of double-strand breaks (DSB) of the genome. Here we will fuse Brex27 to rr-
saCas9 (mirr-saCas9), and conduct experiments to characterize mirr-saCas9, in comparison
with rr-saCas9 and saCas9, with a focus on PAM requirement, on-target editing efficacy, and
off-target rates. The proposed mirr-saCas9, if successful, will add favorable features to saCas9
including: (i) 16 times more targetable sequences as a result of the relaxed PAM requirement
(NNNRRN vs NNGRRT); and (ii) reduced off-target indel rates as a result of enhanced HDR at
off-target sites. Furthermore, the validated computational model is adaptable for the
improvement of other CRISPR variants for PAM modification and other desirable engineering.

Public health relevance
NARRATIVE SaCas9 is a major gene editing nuclease that is preferred for in vivo applications. Here we propose to develop a computational structural biology guided method UniDesign to engineer saCas9 with relaxed PAM requirement, and to improve saCas9’s safety profile by fusing a small size HDR (homology-directed repair)-promoting peptide.